Reverse translational multi-omics to identify treatment targets for atrial myopathy

Project Summary/Abstract
Atrial fibrillation is the most common sustained arrhythmia and its prevalence is increasing. Accumulating
evidence suggests that upstream to atrial fibrillation, structural, mechanical, or electrophysiological changes in
the atria—collectively known as atrial myopathy—may be a primary mediator of heart failure, ischemic stroke,
and mortality in patients with atrial fibrillation. However, the pathophysiology of atrial myopathy is incompletely
understood, there are currently no targeted therapies, and treatment targets suggested by human population
studies remain unvalidated experimentally. Therefore, treatment target validation and understanding the
pathophysiologic mechanisms that contribute to atrial myopathy are unmet needs. This project aims to fill this
gap by identifying novel treatment targets through large-scale human data analysis and by investigating the
protective role of the protein DLK1 in atrial myopathy. The primary aim leverages human cohort data to identify
candidate treatment targets by discovering circulating proteins and metabolites linked to both left atrial function
and atrial myopathy. By combining traditional multivariable linear regression analyses with advanced
genomics-based causal inference methods, we aim to prioritize promising targets for further preclinical
investigation, ultimately paving the way for novel atrial myopathy therapies and improved clinical atrial
fibrillation management. Because prior studies suggest DLK1 protects against fibrosis and inflammation and
our preliminary data found that higher levels are associated with better left atrial function. The secondary aim
of this project will investigate DLK1's role in mouse models of atrial myopathy, testing if increasing atrial DLK1
expression improves left atrial function and if decreasing atrial DLK1 expression impairs left atrial function.
Aiming to become an independent physician-scientist in atrial fibrillation and atrial myopathy research and to
bridge population and basic science, the applicant seeks K08 funding for protected time to solidify his skillset in
characterization of cardiac fibrosis, interrogation of atrial pathophysiology, and Mendelian randomization for
causal inference. This protected research time will give the applicant an opportunity to build his research
program, gather preliminary data, and ultimately secure R01 funding to establish himself as an independent
investigator in the cardiovascular field. The applicant has also assembled an accomplished and well-funded
multidisciplinary mentoring team, comprised of internationally known experts in the fields of atrial fibrillation and
atrial myopathy epidemiology, cardiomyocyte biology, cardiac fibrosis and diastolic dysfunction, and Mendelian
randomization. With their support and guidance, and the research infrastructure available at University of
Minnesota, the applicant is well-positioned to achieve his proposed research aims and accomplish his stated
career development goals. The applicant’s clinical expertise in multi-modality cardiovascular imaging aligns
perfectly with his research goals, enabling him to investigate novel biomarkers and translate research findings
to improve patient care.

Public health relevance
Project Narrative Atrial fibrillation is a serious public health problem because it is the most common arrhythmia and its prevalence is increasing in the aging population, but emerging evidence suggests that upstream to atrial fibrillation, structural and functional abnormalities of the atria termed atrial myopathy is a critical factor driving the adverse cardiovascular and neurocognitive outcomes previously solely associated with atrial fibrillation. The current research will contribute to fundamental knowledge about proteins and metabolites that contribute to atrial myopathy. It will also help train the principal investigator in molecular and statistical research competencies that will enable his transition into an independently funded clinician-investigator.